Endocrine-Disrupting Chemicals: Hazards and Opportunities (ECHO)

PROJECT SUMMARY/ABSTRACT
Increasing numbers of chemicals that enter our daily lives through their use in agricultural,
industrial, and consumer products are now known to have unexpected and, in many cases, very
surprising abilities to interfere with numerous endocrine-regulated systems in humans and other
organisms. Over the past few decades, research on these endocrine-disrupting chemicals
(EDCs) has developed into a field that spans areas ranging from human biomonitoring and
epidemiology to experimental investigations of reproductive, behavioral and metabolic
consequences in model systems to predictive chemistry, green chemistry, and environmental
remediation. The breadth of expertise needed to understand what EDCs do, both alone and in
more environmentally complex exposures, is enormous and compounded by the clinical and
regulatory issues raised by EDCs. The complexity of the field creates significant barriers both to
individual research programs and in the development of cross-disciplinary collaborative
research initiatives necessary to address important questions in a rapidly developing field. Most
institutional training programs with EDC components focus, understandably, on just a subset of
these areas. What is lacking is the opportunity for scientists to step away from their home
programs and immerse themselves in an intensive short course that grounds them in the range
of integrative questions and approaches essential for both for the advancement of their careers
and of the field as a whole.
Taking advantage of the unique facilities at the Marine Biology Laboratory (MBL) in Woods
Hole, MA, we plan to offer such a course, one that is open to advanced graduate students,
postdocs and independent scientists from across the country. This two-week course, Endocrine-
Disrupting Chemicals: Hazards and Opportunities (ECHO), will use a combined
lecture/lab/modeling/discussion approach intended to complement and enhance participants'
research programs by providing them with access to advances in fundamental concepts and
approaches, along with emerging strategies for assessing the hazards posed by EDC
exposures. The course also will provide sessions on effective communication skills, and
guidance on interactions with both the general public and the media. Finally, it will enhance
networks for collaborative, cross-disciplinary relationships at all levels.

Public health relevance
PROJECT NARRATIVE The endocrine disruptor field encompasses diverse disciplines and approaches, but there are few opportunities for immersive experiences that help researchers become familiar with the many inter-related aspects of the field. The proposed course will help bridge gaps in this important emerging field by building a firm foundation and forging cross-disciplinary links among researchers from across career stages and types of institutions.